Prot. NMR Spec. Core

The Protein NMR Spectroscopy Core will focus on protein complex structure determinations, while the Nucleic Acids NMR Spectroscopy Core will focus on determining the structures of nucleic acids, RNA/protein structures, and inhibitor screening.